Training in the Neuroscience of Mental Health

Contact PD/PI: Rasenick, Mark
The objective of this training program (the Biomedical Neuroscience Training Program) is to
develop and train basic and clinical scientists to understand the biology of the brain and mind
and to be well versed in current therapies for psychiatric illness. The trainees are presented
with a program that allows them to do research in a number of laboratories studying anything
from the molecular and cellular biology of neurons to imaging of the brain in psychiatric patients.
This comprehensive program allows trainees to develop novel experimental approaches to both
discovery and therapy. The Biomedical Neuroscience Training Program also instills skills
necessary to help clinical trainees more effectively research the diagnosis, treatment and
prevention of psychiatric disease. Our challenge is to integrate molecular and cellular
neurobiology with higher order systems so that the confluence between brain and mind can be
better understood.
Trainers have been carefully selected to provide an environment where basic and clinical
trainees will enrich each other's experience and learn to work together in the spirit of truly
translational research. These trainers are housed in several departments within the College of
Medicine (as well as a few in the College of Arts and Sciences and Pharmacy) at UIC, but are
committed to the training program as a single entity. Candidates are a mix of graduate students
(both PhD and MD/PhD) and postdoctoral fellows (both psychiatry residents and clinical
psychology fellows). Thus, in addition to research training, a specific goal of the program is to
train psychiatrists/psychologists to engage in research and to excite basic scientists about the
possibility of a career in translational neuroscience. Furthermore, those doing basic
neurobiology become attuned to the implications of their research for mental health. The
program also supports a series of colloquia expected to deliver current data and speculation
about both basic and clinical neuroscience. Finally, it is emphasized that a strength of this
program is its ability to recruit and train underrepresented minorities and to bring them into the
ranks of researchers in neurobiology, psychiatry and clinical psychology. This program is
committed to the principle that ALL trainees benefit from diversity.
Project Summary/Abstract Page 6

Public health relevance
This is a request to fund a training program combining basic neuroscientists and clinicians hoping to gain a fuller foundation in neurobiology. The interactive environment allows these basic neuroscientists and their clinical counterparts to train together so that they appreciate the bidirectional nature of translational neuroscience. This program creates neuroscientists with an understanding of psychiatry and psychiatric scientists with a good feel for the neuroscience that underlies disorders of cognition and mood.